Inactivity, sedentary behavior, and the risk for Alzheimer’s disease in middle aged to older adults

Abstract
Alzheimer’s disease is a devastating progressive neurodegenerative disease that leads to a profound loss
of brain and cognitive functions. There is an urgent need to identify factors that can decrease risk, including
modifiable lifestyle behaviors. Exercise and physical activity (PA) have shown promise in reducing rates of
cognitive decline, brain structural atrophy, and risk of developing Alzheimer’s disease and other related
dementias. However, despite decades of work, and recommendations to improve exercise participation, levels
of PA and engagement in purposeful exercise have not increased greatly. In contrast to PA, the effect of
sedentary behavior (SB) or time spent sitting on Alzheimer’s disease risk has received less attention. SB may
have independent physiological effects on health which may not be fully ameliorated by engaging in PA, and
there is growing evidence that SB may have detrimental effects on cognition and brain structure. Understanding
the effects of SB on Alzheimer’s disease risk may provide a key target for behavioral modification since reducing
time spent sitting may be easier to implement compared to increasing exercise levels in older adults.
In this proposal, we will determine whether time spent in SB is associated with brain health and the risk of
developing Alzheimer’s disease and all-cause dementia. Here, we focus on the effects of SB on cognition, brain
structure, and Alzheimer’s disease incidence in the largest prospective cohort analyzed to date, the UK Biobank.
We will analyze associations between markers of SB including self-report and objective measures from wearable
accelerometers, and cognition, brain health, and incident Alzheimer’s disease and all-cause dementia. This
unique dataset will allow us to determine the best SB predictors of brain aging outcomes, including Alzheimer’s
disease incidence so that interventions can focus on reducing the most harmful aspects of SB in older adults.
Using this dataset along with three replication datasets, we will test our overarching hypothesis that high levels
of SB are associated with increased cognitive decline, poorer brain health, and increased Alzheimer’s disease
risk that is not fully mitigated by complementary engagement in PA. To test this hypothesis, this proposal will
address the following specific aims: 1) to determine how SB is associated with incident Alzheimer’s disease and
all-cause dementia, 2) to evaluate the cross-sectional and prospective relationships between SB and aspects of
cognition and brain structure associated with Alzheimer’s disease risk, and 3) to investigate how displacing SB
with time spent in different PA levels modifies the association between SB and Alzheimer’s disease risk. By
evaluating a novel, comprehensive set of SB markers and testing their associations with cognition, brain
structure, and Alzheimer’s disease risk, this proposal provides a unique opportunity to obtain key data needed
to help advance efforts in developing effective interventions for Alzheimer’s disease prevention.

Public health relevance
Project Narrative This study will investigate the association between sedentary behaviors (SB), brain health, and the risk of developing Alzheimer’s disease and all-cause dementia. Using a comprehensive set of both objective and self- report measures of SB from the UK Biobank, this study will form an essential foundation for developing effective behavioral interventions and prevention therapies for those at increased risk for developing Alzheimer’s disease.